Innate Immune Activation and Endothelial Cell Dysfunction in Acute Kawasaki Disease

More than 25% of children with Kawasaki disease (KD), the most common cause of pediatric acquired heart
disease, develop coronary artery abnormalities (CAAs) despite standard therapy with intravenous
immunoglobulin. Once aneurysms have formed, the damage to the arterial wall is irreversible, such as stenoses
and calcification that may lead to ischemic complications. This collaborative team has established that activation
of the IL-1 pathway and endothelial-to-mesenchymal transition (EndoMT) with downregulation of krüppel-like
factor 4 (KLF4) are key to the pathogenesis of KD vasculitis. Our novel discovery of the central role of TIFA (TNF
receptor-associated factor-interacting protein with a forkhead-associated domain) in NLRP3 inflammasome
activation in endothelial cell (EC) injury is proposed as a further mechanism of KD vasculitis. We propose a bold
plan to unite this research team with expertise in vascular biology, immunology, and clinical KD to unravel the
mechanisms underlying vascular injury in KD and pilot a novel therapeutic approach. The guiding hypothesis
is that acute KD not only activates the IL-1/TIFA/NLRP3 inflammasome in the endothelium, but also reduces EC
homeostasis, both of which are critical in the pathogenesis of KD. The blockade of the IL-1-dependent innate
immune response by anakinra (recombinant IL-1R antagonist) in combination with the restoration of EC function
by atorvastatin will reduce vascular damage in acute KD. Three specific aims are proposed to test this hypothesis.
Specific Aim 1 will delineate the molecular basis by which anakinra blocks activation of the innate immune
response associated with KD vasculitis. In vitro, ex vivo, and in vivo experiments will investigate the role of IL-1,
TIFA, and NLRP3 in KD-mediated EC dysfunction and vasculitis using pathway-specific siRNA knockdown,
recombinant overexpression, pharmacologic agonists and inhibitors (including anakinra), as well as loss-of-
function mice. Specific Aim 2 will elucidate the molecular basis by which atorvastatin restores EC function in
acute KD. Mouse lines with gain- and loss-of-function of KLF4 as well as lineage tracing experiments will be
performed to decipher the molecular mechanisms underlying EC dysfunction in KD vasculopathy. Specific Aim
3 will determine the synergistic effect of anakinra/atorvastatin combination therapy in LCWE-injected mice and
in KD patients. LCWE mouse models, including Tifa-/- and Klf4-/-, will be utilized to test the effect of
anakinra/atorvastatin combination therapy on vascular inflammation and EC function. Furthermore, acute KD
patients with early CAAs will be enrolled in a pilot study of anakinra/atorvastatin combination therapy. Cytokine
levels and MMP activity in sera and transcript abundance in whole blood RNA will be measured pre- and post-
treatment. These sera will also be tested in vitro with cultured ECs with read-outs for EC innate immune
responses and EC dysfunction. The synergistic expertise of the three teams in this multi-PI proposal provides a
unique opportunity to understand molecular mechanisms underlying KD vasculopathy and rapidly translate the
findings into a pilot study in children with in vitro and in vivo assessments of the treatment effect.

Public health relevance
Project Narrative Kawasaki disease (KD), the most common cause of pediatric acquired heart disease, is a systemic vasculitis of unknown etiology that results in coronary artery dilation and aneurysm formation in 25% of children despite timely administration of currently approved therapies. To address an unmet clinical need, three investigative teams will join forces to elucidate the molecular mechanisms underlying disrupted endothelial cell homeostasis and induction of an innate immune response using cultured cells and mouse models. A pilot study of two therapies designed to block these pathways (anakinra and atorvastatin) will be conducted in acute KD patients to test the hypothesis that the induction of an innate immune response and endothelial cell dysfunction can be attenuated with the combined therapies.